ONCOGENE ALTERATION IN MICE INDUCED BY CHLOROPRENE

Male and female B6C3F1 mice were exposed by inhalation to 0, 12.8, 32, or 80 ppm chloroprene for 104 weeks. There were increased incidences of alveolar/bronchiolar adenomas and carcinomas in lungs of female and male exposed to 12.8, 32 or 80 ppm when compared with controls. There was strong exposure-concentration-dependent response, which was especially noticeable when comparing incidences of multiple alveolar bronchiolar adenomas or carcinonas in mice in exposed and control group. K-ras mutation profiles may add some interesting information on mutation frequency and spectra and dose response relationships. This data will be presented in the NTP peer review in December 1996.